CT DoAg Maintenance of the Animal Feed Regulatory Program Standards (AFRPS)

Project Abstract:
Connecticut Department of Agriculture Conformance and Maintenance with the
Animal Feed Regulatory Program Standards (AFRPS)
The specific goal of this project is to establish a cooperative agreement with FDA to continue to advance
efforts at achieving a nationally integrated feed safety system. In Connecticut, this will occur by using
this funding to maintain full implementation of the Animal Feed Regulatory Program Standards (AFRPS)
and continue improving the safety of animal feed in Connecticut. In conjunction with our Feed Contract,
we will be conducting inspections on applicable feed manufacturing firms in Connecticut, collecting feed
samples and conducting complaint investigations along with other animal feed related duties.

Public health relevance
FOOD SAFETY & AG. COMMODITIES STATE OF CONNECTICUT 860-713-2513 ANIMAL CONTROL 860-713-2506 DEPARTMENT OF AGRICULTURE DAIRY/MILKSAFETY 860-713-2508 PRODUCE SAFETY 860-713-2522 LIVESTOCK/POULTRY BUREAU OF REGULATORY SERVICES 860-713-2504 STATE VETERINARIAN 860-713-2505 PAR-20-132 Development and Maintenance of the Animal Feed Regulatory Program Standards with Optional Coordinated Preventive Control Regulatory Activities and Capacity Building (U18) Please see the included Research Plan for the full project narrative for the proposal entitled “ CT DoAg Maintenance of the Animal Feed Regulatory Program Standards (AFRPS)”. Wayne Kasacek, BS, RS Assistant Bureau Director CT Dept. of Agriculture Bureau of Regulatory Services 860-713-2508 [email] 450 COLUMBUS BLVD., SUITE 702 HARTFORD, CT 06103